The effect of donor age on the function and therapeutic efficacy of human hepatocyte-like cells

Project Summary:
Worldwide, 844 million people are afflicted with liver disease, with mortality nearing 2 million deaths per year.
Liver transplantation is the preferred treatment for selected cases but is limited by the availability of high-quality
organs from young donors (<55 years old), and the morbidity associated with the operation. Cell-based therapy
using primary human hepatocytes (PHHs) is a minimally invasive alternative for treatment of select liver
pathologies where architecture is preserved but there are metabolic derangements, such as in acute liver failure
and metabolic liver disease. Optimal metabolic function of the cells is critical for the success of cell-based
therapies. However, PHH therapy is severely limited by the scarcity of donors, and the dramatic decrease in
metabolic function of PHHs from older donors. Human hepatocyte-like cells (h-iHLCs) derived from human
induced pluripotent stem cells (h-iPSCs) emerged as an alternative to PHHs for treatment of select liver
conditions. H-iHLC have three benefits: (1) H-iHLCs are produced from an unlimited, renewable source: h-iPSCs.
(2) They bypass ethical concerns associated with the use of embryonic stem cells. (3) They have the potential
to prevent an allogeneic immune response following transplantation by utilizing the patients’ own cells. Although,
the deleterious impact of age on the metabolic function has been described for PHHs, the impact of donor age
on the metabolism in h-iHLCs has not been studied. Here, we aim to identify the donor age-associated changes
in the overall metabolic profile of h-iHLCs by studying the transcriptome and proteome of h-iHLCs from young
and old donors and compare the results to PHHs from the same donors. We will study in detail the expression
and function of the cytochrome P450 (CYP450) superfamily in h-iHLCs and PHHs as a function of donor age.
Age-related changes in DNA-methylation down-regulate metabolic function including CYP450 activity in PHHs.
Therefore, we will study and attempt to modulate this regulatory mechanism in h-iHLCs with the goal to optimize
the overall metabolic function including CYP450 activity in h-iHLCs. We will examine the therapeutic efficacy of
the generated h-iHLCs in a murine model of acute liver failure by transplanting h-iHLCs into metabolic liver
failure, tyrosemia type I (Fah¯′¯/Rag2¯′¯/Il2rg¯′¯ on NOD-strain background (FRGN)) mice. The results from this
study will provide critical information about the impact of donor age on metabolism and its regulation in h-iHLCs
and will (1) assist in selecting metabolically fit donors for allogeneic h-iHLCs transplantation, (2) allow future
modulation of functional and regulatory mechanisms through alterations in reprogramming, differentiation and
gene editing, to produce high-quality h-iHLCs with optimized metabolic function for allo- and autogeneic
transplantation.

Public health relevance
Project Narrative: Cell therapy using human hepatocyte-like cells (h-iHLCs) has the potential to address the unmet need for high quality and less invasive therapies to treat liver disease. We aim to identify and modulate age-related mechanisms that affect the quality of h-iHLCs with the ultimate goal of making h-iHLCs a safe and practical technology for clinical applications in regenerative medicine, as well as in disease modeling and pharmaceutics.